Moderation of Aging Trajectories of Cognition and Neuropathology by Diet Composition in Middle-aged Nonhuman Primates

PROJECT SUMMARY
Diet composition potently modulates trajectories of brain aging. Intake of a "Mediterranean" diet including fruit
and vegetables, fish, and healthy fats is associated with reduced risk of Alzheimer's disease and related
dementias including vascular dementia. Intake of a "Western" diet high in simple sugars and saturated fat is
associated with increased risk of these conditions. Nonhuman primate models of diet composition effects on
brain health are critical for providing insight into mechanisms of diet effects on the brain, because of challenges
associated with long-term studies of diet manipulations in humans. Our previous work showed Western diet
consumption (compared to Mediterranean) increased social isolation and anxiety-related behaviors, increased
gray matter volume in an Alzheimer's-related temporal-parietal cortex meta-region of interest, reduced white
matter volume, and resulted in lateral temporal transcriptional profiles associated with inflammation in middle-
aged female cynomoglus monkeys. However, because cognitive function was not assessed in these monkeys,
the interpretation of changes in biomarkers as reflecting a nascent pathological process or, alternatively, a
resilient adaptation remains unclear. For example, elevated gray matter volume in monkeys consuming the
Western diet may reflect impaired function associated with inflammation, or a reactive change to preserve
function and promote resilience in the face of a poor diet. Furthermore, males were not studied in our previous
work. To address these critical barriers to progress in the field, we propose to test the impact of Mediterranean
vs. Western diet on cognitive function and translational imaging and fluid biomarkers of Alzheimer's disease
risk, neuroinflammation, and neurodegeneration in middle-aged male and female cynomolgus monkeys, in a
longitudinal design spanning 32 months of diet treatment, corresponding to ~9.5 human years. Our
overarching hypothesis is that consumption of Western diet interacts with aging trajectories to exacerbate
cognitive impairment with aging and produce pathological brain aging, whereas Mediterranean diet promotes
resilient aging, preserved cognitive function, and reduction of markers of Alzheimer's disease risk, including
fluid biomarkers of neurodegeneration and neuroinflammation, and PET imaging measures of microtubule
stability and neuroinflammation. We expect that within and across diet treatment groups and sexes that
elevated markers of neuropathology will predict cognitive decline. This project specifically examines
vulnerability of middle-aged monkeys, a time in the lifespan where trajectories of aging take a turn towards
successful aging or greater risk of neurodegenerative disease, with immense translational significance.

Public health relevance
PROJECT NARRATIVE Diet composition potently modulates brain aging, but the impact of diet on cognitive and brain aging and the mechanistic basis of the relationship between diet and health of the aging brain is still poorly understood. This limits our understanding of the impact of dietary interventions to aid in prevention of neurodegenerative disease. The proposed study will address key questions about the effect of diet on trajectories of cognitive function and brain aging in middle-aged cynomolgus monkeys, a well-characterized model with many similarities to people.